Microscopy Laboratory

PROJECT SUMMARY/ABSTRACT
The Microscopy Core Laboratory Shared Resource (MICROS) provides expert, state-of-the-art, affordable,
and cost-effective light, electron, and cryo-electron microscopy imaging to Perlmutter Cancer Center (PCC)
members and their collaborators, regardless of their pre-existing expertise. As advanced microscopy and image
analysis is central to modern cancer research, MICROS is heavily utilized and essential to all 4 Research
Programs, with TIM, CCB, and CGD the heaviest users. Since the 2018 CCSG review, 55 funded grants and
92 peer-reviewed publications used MICROS data. MICROS is directed by Feng-Xia (Alice) Liang, PhD an
internationally recognized expert in the field with >30 years of experience in microscopy and >15 years of
experience as a shared resource director. Dr. William Rice oversees cryo-EM services and has >20 years of
experience and >60 publications. MICROS has nine expert staff members who fully support PCC members with
project consultation, experimental design, sample preparation, imaging, data analysis and interpretation, high
resolution structure determination, and curated image data for grant applications and publications. During the
funding cycle, MICROS expanded and relocated to newly renovated space that houses a centralized light
microscopy suite, an adjacent cryo-EM suite, and a nearby electron microscopy suite for state-of-the-art TEM
and SEM. The new suites provide updated data networking, new instruments, imaging technology, and advanced
imaging services to PCC members, including 2D and 3D imaging and optimized high-throughput and superresolution
microscopy. MICROS shares and disseminates technological expertise to drive multidisciplinary
collaborations, while ensuring quality control of imaging data, instrumentation, equipment, and data provenance.
Like most other shared resouces, MICROS is overseen by the Division for Advanced Research Technologies,
has an advisory board of PCC members and other NYU faculty and solicits yearly surveys to assess member
needs. The Specific Aims of MICROS are 1) To provide PCC members with cost-efficient, high quality, state-ofthe-
art access to, and expertise in, the latest cutting-edge imaging technologies, including optical microscopy,
two- and three-dimensional (2D and 3D) electron microscopy, and cryoEM, and evaluate and implement
emerging imaging technologies, 2) To provide PCC members with consultation, experimental protocol design,
and training in high resolution structure determination, image analysis and interpretation, and image data
management, 3) To educate and inform the PCC scientific community about advanced imaging technologies
and applications to cancer research through frequent informational advanced microscopy seminars, instrument
demos, the weekly PCC Faculty Lunch, and presentations/posters at the PCC Retreat and other institution-wide
seminar series.